Hv1 in Pulmonary Hypertension

ABSTRACT
The development of pulmonary hypertension is associated with oxidative stress, endothelial
dysfunction, and pulmonary vascular remodeling. Pulmonary vascular remodeling is involved in
proliferation and phenotypic transformation of pulmonary endothelial cells and smooth muscle cells.
And endothelial dysfunction influences endothelial cell proliferation, and differentiation, leading to
endothelial apoptosis-resistant hyperproliferation underlying the pathogenesis of pulmonary
hypertension. The voltage-gated proton channel Hv1 has been shown to promote the production of
NADPH oxidase (NOX)-derived reactive oxygen species (ROS) and plays an essential role in the
regulation of cell proliferation and apoptosis. Here we discovered that Hv1 was implicated in
pulmonary hypertension. The expression of Hv1 was significantly upregulated in the lungs of
multiple rodent models of pulmonary hypertension and pulmonary hypertension patients. Moreover,
deficiency of Hv1 reduced pulmonary hypertension burden in mouse model of hypoxia-induced
pulmonary hypertension. To explore the role of Hv1 in the pathogenesis of pulmonary hypertension,
we will apply transgenic mice and complementary in vivo approaches to delineate the contributions
of Hv1 to the development of pulmonary hypertension. We plan to examine the molecular
mechanisms of Hv1-mediated pulmonary hypertension and determine how Hv1 regulates the
progression of pulmonary hypertension. Additionally, the Hv1 blockers will be applied to assess the
translational potential of targeting Hv1 for treatment of pulmonary hypertension.

Public health relevance
PROJECT NARRATIVE Pulmonary hypertension is a severe vascular disease, accounting for millions of deaths over the past decades. We discovered that Hv1 protein participated in the development of pulmonary hypertension, and plan to investigate the roles of Hv1 in the pathogenesis of this disease and to explore the translational potential of targeting Hv1 for treatment of pulmonary hypertension. If fruitful, the proposed study will present a novel target against pulmonary hypertension and shed light on a new strategy for the therapy for this severe disease.